Examination of Initiating Factors that Regulate Red Blood Cell Alloimmunization

Summary: Despite being one of the most common interventions in hospitalized patients, red blood cell (RBC)
transfusion is not without risk. Exposure to allogeneic RBCs can result in RBC alloimmunization, which can make
it difficult to find compatible blood for future transfusions and directly increases the risk of transfusion
complications. To develop strategies that can actively inhibit alloimmunization, key initiating factors that drive
alloantibody formation against RBC alloantigens must be defined. The overall objective of this proposal is to
define key initiating factors that contribute to short- and long-term alloantibody production. Our central hypothesis
is that complement serves as a key molecular adjuvant that can drive alloimmunization through a CD4 T cell
independent (TI) pathway, but that CD4 T cells are required for long-term alloantibody production. Our
hypothesis is formulated on the basis of our recent discovery that while initial anti-KEL IgG antibody formation is
TI, in the absence of complement component 3 (C3), anti-KEL IgG antibody formation is completely CD4 T cell
dependent (TD), suggesting that RBC surface bound C3 may directly drive TI IgG antibody formation. Consistent
with this, complement receptors 1 and 2 (CR1/2) on B cells are required for KEL RBC-induced TI IgG antibody
production. Our data also demonstrate that patients with sickle cell disease (SCD) experiencing acute chest
syndrome (ACS) are not only much more likely to become alloimmunized, but also experience significant
complement activation, suggesting that complement activation may enhance RBC alloimmunization following
transfusion during ACS. In contrast, for long-lived alloantibody production to be realized, CD4 T cells must be
engaged. Using the same KEL model system, our data demonstrate that despite CD4 T cells not being required
for initial IgG alloantibody formation, KEL RBCs activate T follicular helper cells (TFH) and follicular (FO) B cells,
and that long-lived alloantibody production is TD. In contrast to the requirement for C3 for TI IgG alloantibody
formation, while initial alloantibody formation occurs in the absence of toll-like receptors (TLRs), TLR-signaling
is required for persistent alloantibody production. Taken together, these data suggest that KEL RBC transfusion
can simultaneously engage two distinct immune pathways through a complement-regulated process. To test
this, we will weld pre-clinical and clinical studies to test the following specific aims. Aim 1: Define the role of C3
in driving TI MZ B cell-mediated antibody production. Aim 2: Define the role of TLR signaling and 33D1+
DCs in driving TFH and FO B cell formation and long-lived antibody production. We think that successful
completion of these aims will provide a unique opportunity to define key factors that initiate distinct types of RBC
alloimmunization with the promise of identifying key targets to prevent RBC alloimmunization.

Public health relevance
Narrative: Red blood cell (RBC) alloantibody formation can cause significant complications, especially in transfusion-dependent patients. Despite this, the key initiating factors that govern RBC alloimmunization remain incompletely defined. This project will leverage clinical and pre-clinical studies to define key immune factors that dictate short-term (evanescent) and long-term (persistent) alloantibody production with the goal of identifying distinct targets that may prevent or reduce alloantibody formation in at-risk patients.